Implications of hospital-physician integration for urban-rural equity in access, care coordination, and outcomes.

PROJECT SUMMARY
Dr. Brady Post’s long-term goal is to explain how system-level integration affects quality and equity, specifically
for rural residents. The American health care system has moved quickly toward greater integration between
hospitals and physicians. As a way to organize healthcare services, hospital-physician integration has
generated much controversy within the health policy community. Advocates hope for more efficiency and care
coordination while skeptics raise concerns over costs and quality. This pressing policy issue, poised to be a
defining issue in health care for decades to come, requires dedicated scholars. Dr. Brady Post has focused his
scholarship on this topic since his doctoral studies at the University of Michigan and he continues to build the
evidence base as an Assistant Professor at Northeastern University. A natural next step in his career is to
advance the science on hospital-physician integration using a more sophisticated set of methodological
approaches that will round out his skillset and, simultaneously, help to fill persistent gaps in the literature.
Through a comprehensive training plan that includes formal coursework and mentored, project-based learning,
this project will equip Dr. Post with (1) deep knowledge of rural health needs, policy, and service delivery (2)
qualitative and mixed-methods techniques, and (3) survey design and measurement theory needed for survey
research. This unique combination will position Dr. Post to direct innovative studies of how hospital-physician
integration reshapes health care in rural communities. This training will build his skills as an independent
researcher and prepare him to successfully compete for R01-level grants. This project will examine the effects
of hospital-physician integration on care coordination, patient access to care, and disparities in health
outcomes across rural and urban areas. It will leverage rich survey data to highlight patients’ perspectives and
use in-depth interviews to highlight physicians’ and mangers’ perspectives. With this award, Dr. Post will bring
new concepts and new approaches to the literature on hospital-physician integration at a time when the
Centers for Medicare and Medicaid Services, the Federal Trade Commission, and other policymakers are
actively weighing the benefits and drawbacks of increased integration. This proposal directly answers AHRQ’s
request for health services research to advance health equity (NOT-HS-21-014) and focuses on the AHRQ
priority population of rural residents. This award will support Dr. Post’s transition to independence, establishing
him as a leading scholar on the quality and equity implications of increasingly integrated health care systems.

Public health relevance
Public Health Relevance Project Narrative: The goal of this career development award is to transition Dr. Brady Post to independence as a health services researcher with a long-term research agenda focused on how system-level integration of providers affects quality and equity. Rapid and widespread integration between hospitals and cardiologists has unknown consequences for health equity, particularly among rural residents. This grant will apply mixed methods to collect insights from physicians, managers, and patients, providing the evidence needed to develop an effective policy response to the opportunities and dangers presented by widespread hospital-physician integration.